STAGE 2 RECRUITMENT AND FOLLOW-UP STUDY OF PREGNANCY AND NEONATAL HEALTH (SPAN) - DUKE UNIV

The Division of Population Health Research (DiPHR) at the Eunice Kennedy Shriver National Institute of Child Health & Human Development (NICHD) designs and conducts original epidemiological, behavioral, and biostatistical research encompassing several research domains such as human reproduction and development, pregnancy, and related complications, pediatric and adolescent health and behaviors, and methodologic research relevant for its mission. Under the developmental origins of health and disease (DOHaD) hypothesis, early life exposures can “program” an individual for health and chronic disease risk through cellular adaptations to biological processes. Prenatal exposures and genetic factors impact fetal growth and development and neonatal health, important determinants of life-long health and disease. DiPHR proposes an approach to examine a) the father’s role, and b) placental determinants in relation to fetal and neonatal health and development.
The contractor(s) shall participate in the ongoing recruitment and follow-up of approximately 1800 pregnant women, of whom approximately 1300 are self-reported African American and 500 other race/ethnicity, and additionally recruit approximately 1000 couples of any race/ethnicity. For this Task Order, the contractor is required to carry out the Recruitment & Implementation for Stage 2 of the SPAN Study.